Defining rates of cognitive aging in adults with and without dementia using the CODA cohort

PROJECT ABSTRACT
Objective: The purpose of this application is to identify a rate of normative cognitive aging (i.e., cognitive aging
in individuals without a neurocognitive disorder), and determine how much quicker cognitive aging is among
individuals living with Alzheimer disease or related dementias (AD/ADRD). Using data from the Children of the
Depression (CODA) cohort of the Health and Retirement Study (HRS), we will first identify a latent variable
estimate of general cognitive performance (Aim 1). Afterwards, we will identify the pace of normative cognitive
aging in standard deviations per year (SD/year), both unadjusted and adjusted for known covariables that
influence cognition (e.g., age, sex, race and ethnicity, education; Aim 2). Finally, we will use Centers for
Medicare & Medicaid Services (CMS) data linked to the HRS to identify participants who receive a dementia
diagnosis during follow-up, and determine how much faster cognitive aging is among individuals living with
AD/ADRD (Aim 3). In line with PAR-23-179, this proposal will also develop the career for early-stage
investigator, Dr. Kunicki, and will serve as a basis for future NIH grant proposals.
Significance: Cognitive ability declines with age, and tends to aging quicker later in life. Whereas
neurocognitive disorders such AD/ADRD are known to increase the rate of cognitive aging, there is no well-
established reference of normative cognitive aging. Lacking this reference pace makes it difficult for
researchers to evaluate the results of their studies (i.e., determining if a cohort is declining at a normal or
quicker than usual pace). Moreover, we will estimate how much quicker cognitive aging is among individuals
living with AD/ADRD.
Approach: We will use data from the CODA cohort of the HRS, which is comprised of over 2,000 participants
aged 68-74 at baseline with 22 years of follow-up data available. Using the HRS cognitive measures, we will
identify a latent variable of cognitive aging, and use the latent variable to identify the pace of normative
cognitive aging in SD/year. Then, using CMS data, we will identify participants who received a dementia
diagnosis during follow-up and determine how much faster cognitive aging is among individuals living with
AD/ADRD. Sensitivity analyses will also examine the pace of normative cognitive aging by different cognitive
domains.
Innovation: This study is innovative because it addresses a major gap in the literature in cognitive aging by
identifying a pace of normative cognitive aging and among individuals living with AD/DARD. These paces will
be useful for researchers to use as reference points to interpret results of clinical trials to slow cognitive aging.
Despite a lack of normative cognitive aging rates being a well-known issue in the field of aging, this study will
be the first to identify a nationally representative rate of cognitive aging among older adults.

Public health relevance
PROJECT NARRATIVE Cognitive ability declines with age, and declines quicker when living with Alzheimer disease or related dementias (AD/ADRD), but a reference for normative cognitive decline without any neurocognitive disorder is currently unknown. This is a major gap in the literature because researchers cannot accurately judge the results of their study outcomes because there is no reference point to determine how much quicker decline is occurring in individuals living with AD/ADRD. This study proposes to fill this gap by identifying a pace of normative cognitive aging, and determining how much faster decline is in individuals living with AD/ADRD.